CIRCA Administrative Core

PROJECT SUMMARY
The Administrative Core (AC) provides the foundational support necessary for achieving the
overarching goals of Center for Integrative Research on Childhood Adversity (CIRCA). The
CIRCA administrative core has three primary functions: a) providing administrative, fiscal, and
scientific management of the Center; b) supporting the research and career development goals
of CIRCA research project leaders (RPLs); and c) coordinating the development of sustainable
research cores supporting interdisciplinary approaches to the study of childhood adversity and
its effects on health. By design, CIRCA is integrative in nature, coordinating and
combining studies across the spectrum of translational science to develop a more
comprehensive understanding of biobehavioral mechanisms and developmental
processes that will inform solutions to enduring and intergenerational childhood trauma.
The AC will support the overall aims of the Center with sound administrative and fiscal
management practices, providing effective internal and external communication, coordinating
training and education programs, conducting ongoing process and outcome evaluation, and
supporting the development of sustainable research cores.

Public health relevance
PROJECT NARRATIVE The administrative core (AC) will support the proposed Phase 2 Center for Integrative Research on Childhood Adversity (CIRCA). The AC will ensure mentoring and training for research project leaders and pilot project investigators to support a research trajectory inclusive of independent research funding from the National Institutes of Health. Centralizing administrative activities allows investigators to focus on their science. The AC is designed to nurture innovative and collaborative science to address intergenerational transmission of adversity. Collectively the AC will build research support and infrastructure at CIRCA-affiliated institutions.